Shape-based personalized AT(N) imaging markers of Alzheimer's disease

Abstract
The AT(N) framework of Alzheimer’s disease (AD) provides a systematic guidance to study AD based on
quantitative measures of biological markers of β-amyloid (Aβ) plaques (A), neurofibrillary tau tangles (T), and
neurodegeneration (N). Existing AT(N) imaging markers are typically defined as average measures of cortical
regions determined a priori, which are insufficient to characterize the heterogeneous pathology and atrophy
patterns of AD. To allow more personalized characterization of the AT(N) status of individual subjects, we will
develop in this project novel imaging markers based on advanced shape analysis techniques. From the
perspective of imaging marker development, challenges to study the heterogeneity of AD can arise from multiple
sources. The first is the frequent existence of atypical AD pathology and brain atrophy patterns that deviate from
canonical Braak stages. The second is the high variability of cortical anatomy and the resulting large variations
of cortical thickness at so called “corresponding” locations of even healthy brains. The third is the current lack of
understanding about the role of AT(N) imaging markers in characterizing the diverse disease trajectories in
minority groups including African Americans and Mexican Americans. Building upon our extensive experience
in brain shape analysis, we will develop tools to quantify the topographic pattern of cortical tau and Aβ pathology,
build a personalized analysis framework for the early detection of localized brain atrophy, and apply these tools
to the multi-ethnic cohort from the Health & Aging Brain Study – Health Disparities (HABS-HD) (n=3000) to
characterize the heterogeneity of AT(N) imaging markers in diverse populations. There are three specific aims
in our project: 1. To develop surface-based modeling of topographic patterns in tau and amyloid PET imaging
for personalized subtyping and staging of AD pathology. 2. To develop personalized imaging measures of brain
atrophy by resolving variability due to cortical folding and shape differences. 3. To characterize the impact of
health disparity on disease staging and subtyping with personalized imaging markers. In summary, our main
goal is to create novel computational tools for the creation of personalized AT(N) imaging markers and apply
them to characterize the heterogeneity of AD pathology in the context of health disparity. All tools and imaging
markers developed in this project will be distributed freely to research community, which we believe will greatly
enhance the state-of-the-art in the subtyping and staging of AT(N) pathology in diverse populations.

Public health relevance
Relevance to Public Health Our project will provide novel imaging markers for the personalized and more accurate characterization of the AT(N) status of subjects at risk of Alzheimer’s disease (AD). The personalized cortical thickness analysis algorithms from our research will greatly improve the early detection of brain atrophy due to AD. Our research will also enhance our understanding about the role of AT(N) imaging markers in characterizing the diverse disease trajectories across racial and ethnic groups.